Bigfoot Spectral Cell Sorter

This request is for funds to purchase a biocontained ThermoFisher Bigfoot spectral sorter (7 laser, 60 detector).
There is no full-spectrum cell sorter at the University of Pittsburgh or within 100 miles. Unique as an instrument,
the Bigfoot sorter combines the strengths of high-parameter, high-content imaging (multi-laser, high-detector)
with modern full-spectrum technologies (algorithmic spectral unmixing). Our ongoing NIH-funded research is
hampered by the inability to directly transition complex, validated panels from Pitt's three spectral
analyzers to an equivalent spectral cell sorter. In spectral approaches, the full spectrum of light emitted from
each cell is collected by multiple detectors followed by unmixing to separate the signal into individual markers.
Spectral cytometry expands parameter space by permitting the use of new fluors and also new combinations of
existing fluors that could not previously be paired together in conventionally configured cytometers (i.e., one
detector, one color systems). All of the sorters at Pitt are the conventional configuration type. The consequence
is that most or all of our highly complex immunophenotypic spectral panels have to be scaled down, adapted to
fewer detectors, and re-validated for compatibility with existing conventional sorters, all of which fails to capture
the original complexity and novel information tantalizingly revealed by the spectral analyzers. Further, our current
conventional sorters are heavily used. A very attractive feature of the Bigfoot is that it that has two operational
modes, spectral and conventional. Thus, the Bigfoot meets the demands of users with high-complexity spectral
sorting needs, and also benefits all users of our very busy core who have conventionally compensated needs.
The requested Bigfoot spectral sorter will be housed within the centralized Unified Flow Cytometry Core in Pitt's
School of Medicine. The core serves over 180 Pis and 500 individual users. For the proposed instrument, Major
Users include 10 Pis (9 NIH funded) with another 7 Pis as Minor Users. Together, these Pis have over $30 Min
NIH-funded direct costs from at least 5 different institutes. A major research focus is in the broad area of
immunology and allied immune diseases, with sister disciplines such as transplantation, dermatology, vascular
biology, infectious disease, and oncology also well represented. Our preliminary and demo work proved to us
that this instrument will truly allow our investigators to break new ground in their research. The Bigfoot will be
well cared for by the staff of the Unified Flow Cytometry Core, which has an extensive infrastructure and culture
in place to support panel design, oversee instrument operations, and ensure that it is financially self-supporting.
In addition to providing unique and much needed spectral sorting capabilities, the instrument will accommodate
demands for configurable sorts including 6-way sorts into tubes and direct sorting into 1 Ox chips, and allow for
better detection and efficient sorting of rarer events. The sorter has an integrated Class II biosafety cabinet. The
requested Bigfoot will provide the first state-of-the-art spectral sorter instrumentation at Pitt to meet the
high-complexity, high-content needs of our user base and advancing research programs.

Public health relevance
Functional studies of the different immune cell subsets as well as single immune cells provides enormous insights into human well-being. This application seeks funds to purchase a cell sorting instrument that allows researchers to isolate to the highest purity both common immune cell types and very rare immune cell types in order to better understand immune cell activities in health and disease. This instrument will accelerate the studies of a group of researchers with >$30M in NIH funded grants in the areas of immunology, cancer biology and infectious disease.